SERVICE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. NAC provides service to the wide neuroscience community by making core technologies available. In addition to computation and software support and consultation, education and training in using the equipment and software are offered. All current released versions of software and data sets are available for download from our website.